An Antimicrobial Dermal Regeneration Template for application in challenging wound environments

PROJECT SUMMARY/ABSTRACT
Successful and definitive closure of a wound is often jeopardized by microbial contamination or even
colonization, particularly in patients requiring surgical treatment of traumatic injury. The risk of infection is
increased due to potential exposure of critical structures like tendons, ligaments, and bone, which can quickly
deteriorate without adequate coverage. Traditional treatments and wound care devices may be limited by the
need for specific handling or storage conditions, which can be challenging to maintain in dynamic or resource-
constrained environments. These factors underscore the urgent need for innovative, readily accessible wound
treatment solutions that can stabilize injuries, prevent infection and moisture loss, and enhance recovery
outcomes in patients awaiting comprehensive surgical care. Conventional wound dressings, including
antimicrobial products such as silver containing fabric dressings, may reduce bacterial burden, but concerns
regarding cytotoxicity, delayed wound healing and inconsistent antimicrobial performance have limited their
clinical benefit. Even when these dressings “work” as intended, they do not directly contribute to wound closure.
Although tissue-engineered viable cell grafts like Apligraf® and Dermagraft® and dermal regeneration scaffolds
(DRS) such as Integra® Bilayer Matrix can provide wound coverage and directly contribute to definitive wound
closure, they will inevitably fail when placed in even minimally contaminated wounds.
Our current proposal aims to address these challenges by developing DermiSphereTM Shield, an antimicrobial
dermal template tailored for wound healing in a potentially contaminated environment. This template will
induce rapid and robust cellular infiltration and promote angiogenesis, essential for neodermis formation and
wound healing, and incorporate antimicrobial properties to combat infection. Because DermiSphere Shield™ will
contain a broad spectrum non-molecular antimicrobial and becomes vascularized within days, the device is
rapidly transformed into living tissue, protected by the patient’s own immune system, rendering it much more
resistant to infection, even in suboptimal wound scenarios. The overall goal of this SBIR Phase I proposal is to
demonstrate feasibility of DermiSphere Shield as a device for the management of suboptimal (i.e. contaminated
or prone to infection) wounds achieved by regeneration of a functional, stable, vascularized neo-dermis. We will
accomplish this by 1) developing 3 lead formulation prototypes that maximize antimicrobial properties of the
prototype while minimizing its effects on mechanical properties and cytotoxicity; 2) confirming the unimpaired
ability of the antimicrobial prototypes to promote tissue regeneration in clean wounds in vivo; and 3) demonstrate
the efficacy of the best formulation in a contaminated, clinically relevant swine model. The commercialization of
DermiSphereTM Shield is expected to improve clinical practice in the fields where treatment of contaminated or
potentially contaminated wounds (for example burn wounds, diabetic foot ulcers) is common by significantly
decreasing the time and number of procedures required to achieve a healed wound.

Public health relevance
NARRATIVE There is an urgent need for innovative, readily accessible wound treatment solutions that can stabilize injuries, prevent infection, and enhance recovery outcomes in patients awaiting comprehensive surgical care. The successful outcome of this proposal will result in an antimicrobial dermal template tailored for wound healing in a potentially contaminated environment. By accelerating wound healing and reducing the risk of complications, our approach has the potential to significantly improve patient outcomes and reduce healthcare costs.